Pyocins as antibacterials to treat Pseudomonas aeruginosa infections

PROJECT SUMMARY/ABSTRACT.
Pseudomonas aeruginosa is a naturally antibiotic resistant bacterial pathogen that causes severe and deadly
acute and chronic infections, particularly in compromised individuals. New therapeutics are needed to treat such
infections, as P. aeruginosa is often resistant to commonly used antibiotics. Recently, phage therapy has
reemerged as an approach to treat infections caused by P. aeruginosa. The advantage of phages is that they
can specifically lyse target bacteria. However, phages replicate and can potentially transfer genetic material
including antibiotic resistance or virulence genes from one bacterium to another. Instead of phages, we propose
to test the efficacy of the bacteriocins, R-pyocins, as therapeutic agents to treat P. aeruginosa infections.
Bacteriocins are antimicrobials produced by a bacterium that are active against the same species. R-pyocins
are specifically produced by P. aeruginosa and are related to the contractile tail of P2 bacteriophages, but lack
the phage head structure, have no nucleic acids, and thus cannot replicate. R-pyocins can be grouped into three
subtypes (R1, R2, and R5) that differ based on their binding to specific sites on the P. aeruginosa
lipopolysaccharide structure. Despite the apparent efficacy of R-pyocins against many P. aeruginosa in vitro,
there have been relatively few studies validating R-pyocins in mouse models of infection and only a single
published study has been reported using a murine model of lung infection. The goal of this new NIH
Exploratory/Developmental Research Grant Award (R21 Grant) is to assess P. aeruginosa susceptibility to R-
pyocins under in vitro conditions that mimic the lung environment and also in an acute mouse respiratory model
of infection. We hypothesize that R-pyocin susceptibility testing in this more infection-relevant growth
environment will provide a better indication of true susceptibility and testing additional isolates in vivo will provide
the much-needed justification for further consideration of R-pyocins as therapeutics agents.

Public health relevance
PROJECT NARRATIVE. New methods are needed to kill the deadly antibiotic-resistant opportunistic pathogen, Pseudomonas aeruginosa. R-pyocins are a group of lytic antimicrobials that target the outer lipopolysaccharide core and have been shown to be effective at killing susceptible P. aeruginosa isolates under laboratory conditions, however whether resistant isolates might be similarly susceptible under conditions that more accurately mimic those ongoing during infection is not known. We propose to test the R-pyocin susceptibility of a panel of P. aeruginosa isolates under conditions relevant to the cystic fibrosis lung environment and in an acute murine respiratory model of infection to provide the much-needed justification for further consideration of R-pyocins as potential antibacterial agents to treat P. aeruginosa infections.